Mechanistic inquiry of GPR68-mediated neuroprotection against post-stroke deficits and VCID

ABSTRACT
Stroke leads to acute brain injury and is one of the leading causes of long-term disabilities, which include the
development of vascular cognitive impairment (VCI) and post-stroke dementia. Defining new neuroprotective
mechanisms following stroke is essential for alleviating both neuronal injury at acute stage and for protecting
against post-stroke VCI and dementia. The most common type of stroke in human patients is ischemic stroke.
During ischemia or following reperfusion, brain acidification occurs. Acidosis can have both pro-injury and
protective effects. In our previous studies, we found that GPR68, also known as ovarian cancer G protein coupled
receptor 1 (OGR1), a proton-sensitive G protein coupled receptor (GPCR), is widely expressed in the brain and
mediates acid-induced signaling in brain neurons. Our data further suggest that GPR68 activation protects
neurons in acidotic and ischemic conditions. To further our knowledge on GPR68-dependent protection, this
application will investigate the molecular mechanism by which GPR68 elicits neuroprotection. Using in vitro and
in vivo models, we will determine a novel mechanism by which GPR68 induces unfolded protein response (UPR)
in neurons. Further, we will assess the translational potential of pharmacological targeting of GPR68. We will
perform long-term behavioral assessment to determine whether GPR68 potentiation offers protection against
the development of post-stroke disabilities, including post-stroke VCID. Results obtained from the proposed
study will uncover novel protective mechanisms mediating GPR68-mediate neuroprotection and generate critical
information for novel therapeutic approaches through targeting GPR68 to alleviate post-stroke dementia.

Public health relevance
PROJECT NARRATIVE Stroke is one leading cause of long-term disabilities and a risk factor for developing post-stroke VCI and dementia. This proposal will focus on acid signaling and investigate novel GPR68-dependent protective mechanism following ischemic stroke. The results from the proposed studies will have broad implications for our understanding of ischemic brain injury and translational targeting of GPR68 to alleviate neurotoxicity and post- stroke VCID.